Defining the cause and consequence of aging-specific platelet specification from hematopoietic stem cells

PROJECT SUMMARY/ABSTRACT
The goal of this proposal is to understand the mechanisms regulating platelet (Plt) production and function upon
aging. Plts play essential roles in hemostasis, the process of preventing bleeding. Aging is associated with a
dramatic increase in platelet-related disorders, including alterations in Plt numbers (thrombocytosis or
thrombocytopenia) and in Plt hyperreactivity. Plts have a very short half-life of only a few days and are therefore
continually produced by hematopoietic stem cells (HSCs). HSCs are long-lived and undergo a number of
molecular and functional changes with age; thus, we postulate that Plt aging is a consequence of properties
inherited by their long-lived HSC source. Excitingly, we have discovered that the differentiation pathways of Plt
production are different in young and old mice. We hypothesize that the aging-specific Plt pathway contributes
to the dramatically increased risk for Plt-related disorders in the elderly. Here, we propose to investigate the
molecular and cellular mechanisms driving the aging-specific differentiation path, and the consequences for Plt
function and aging physiology. Our discovery of a new, age-specific differentiation path from HSCs to Plts
provides a unique opportunity for novel discoveries towards mitigating Plt-related disorders, including thrombosis
and cardiovascular disease, in the elderly.

Public health relevance
PROJECT NARRATIVE This proposal will investigate the mechanisms regulating the production and activity of platelets, the main mediators of blood clotting. We aim to understand how platelet generation is altered during aging. The findings will inform strategies for mitigating platelet-related disorders such as stroke and thrombosis that frequently plague the elderly.